Bacteriophage interactions with enteric pathogens

Project Summary
How phages and viruses recognize their specific host cell receptors is not known for the vast majority of
species. The long-term goal is to understand the general principles behind the structures and mechanisms that
control host cell entry for bacteriophages. The objective of this proposal is to determine the structures, and
mechanisms of how phages use both outer and inner membrane proteins for infection in enteric pathogens
such as Shigella, E.coli and Salmonella. The central hypothesis is that there are conserved protein structures
and corresponding mechanisms that govern phage entry for the majority of phage:host pairs. We predict that
there are universal cell surface features that are generally required for phage entry, and also other cell surface
features that may be specific to individual phage:host pairs. The rationale underlying the proposed work is that
we will identify key receptor proteins in enteric pathogens that mediate phage infection, and that a better
understanding of these interactions will provide physical targets for either identifying new therapies or
improving existing ones. We will pursue this research using a combination of conceptual and technological
innovations involving genetics, biochemistry and biophysics. These include innovations recently developed in
my laboratory, as well as more established microbiological techniques. The proposed research is significant,
as it will provide both structural and mechanistic insights into how phages dock to their specific hosts, a
necessary step for productive infection. This work will also develop resources that will be used by other
researchers. For example, the proposed work will develop widely-applicable complex transposon and single
gene deletion libraries, which will greatly propel research forward in Shigella, as currently no such genetic
toolkit exists. The expected outcome of this work will provide a basic understanding of how phages attach to
hosts including which proteins and interactions are universally required, and which are specific to individual
phage:host pairs. Additionally, we will gain an atomic level understanding of the protein:protein binding
interactions and transient infection intermediate states that control infection. Atomic level details, such as how
phages bind to their hosts are critical for engineering new therapeutics or enhancing existing ones.

Public health relevance
Project Narrative The proposed research project is relevant to human health because antibiotic resistance is a growing problem threatening long-term global health outcomes and enormous associated costs. Bacteriophage are rising as an attractive supplemental or alternative therapy to combat bacterial infections, and an understanding of how phage structures mediate entry into bacterial hosts through the use of specialized receptor proteins is expected to give rise to new or improved uses of therapeutic phages. Therefore, this proposal is directly relevant to the NIGMS mission of supporting basic research to increase our general understanding of key biological processes that ultimately will lay a foundation for disease treatment.